Safety &effectiveness of dihydrotestosterone-gel for hormonal replacement in eld

To obtain long-term effectiveness and safety data for up to 24 months for patients completing the first part of this study testing Dihydrotestosteronegel preparation. This is a method of hormone replacement therapy for men who have low levels of the male hormone testosterone.